ILEAL POUCH ANAL ANASTOMOSES PERFORMED BY EXCISING THE ANAL TRANSITION ZONE

Objective data of function and quality of life, and objective data of anal and rectal motility will be collected at 2, 6, and 12 months postoperatively.